IGF::OT::IGF. OTHER FUNCTIONS. NCORP Disparities Integration Working Group Support (2018 - 2019)

The NCORP requires program support for the NCORP Disparities Working Group, including Research Interest Groups, and associated activities.